Sinus Disease in Young Children with Cystic Fibrosis

PROJECT SUMMARY/ABSTRACT
Cystic fibrosis (CF) is a chronic, multi-organ process characterized by inspissated secretions that adversely
impact the upper and lower airway, gastrointestinal tract, and other organ systems. Chronic rhinosinusitis (CRS)
is a prevalent and clinically impactful disease complication in individuals with CF. CRS is detrimental to quality
of life, impairs pulmonary status and worsens overall disease state. Olfactory dysfunction is a key feature of
CRS, further worsens quality of life, and is associated with depression and nutritional alterations. These
comorbidities are significantly understudied in young children with CF (YCwCF). Highly effective CF
transmembrane conductance regulator modulator therapy (HEMT) improves pulmonary health and certain extra-
pulmonary domains for adults with CF. Previous research showed that adults with CF have substantial
improvement in CRS after HEMT initiation. However, prior work demonstrated that adults treated with HEMT did
not have improvements in olfactory dysfunction or have complete resolution of sinus disease. Given that airway
inflammation and infection are present for a short time in young children (before starting HEMT), we anticipate
that initiating therapy at an early age will lead to substantial improvement in CRS and olfactory dysfunction. The
goals of this study are to characterize CRS and olfactory dysfunction in YCwCF and test the hypothesis that
these comorbidities improve with HEMT. This prospective, observational, multi-center study will pair with a
prospective, observational, multi-center study of outcomes in YCwCF that will investigate changes in other
domains (pulmonary, microbiological, endocrine, and gastrointestinal) following initiation of HEMT. In this study,
CRS and olfactory dysfunction will be evaluated using validated, age-appropriate, objective and subjective, non-
invasive outcome measures. A treatment group will be comprised of YCwCF who initiate HEMT. A control group
will be comprised of YCwCF who do not initiate HEMT. Both groups will be followed for two years and the groups
will be age-matched. Analysis will use mixed-effect models for longitudinal data to compare outcomes between
groups and incorporate propensity scoring. Specific Aim 1 will characterize CRS and olfactory dysfunction in
YCwCF. Specific Aim 2 will test the hypothesis that HEMT improves CRS in YCwCF utilizing sinus magnetic
resonance imaging opacification and sinonasal symptom burden. Specific Aim 3 will test the hypothesis that
HEMT improves olfactory dysfunction in YCwCF using olfactory bulb volume, quantitative olfactory function,
olfactory cleft opacification, and olfactory-specific quality of life. Findings from this research will inform strategies
that will lead to greater overall health status and improved quality of life. Results will highlight the importance of
complication evaluation and management early in life.

Public health relevance
PROJECT NARRATIVE Chronic rhinosinusitis and olfactory dysfunction are clinically impactful and understudied complications of cystic fibrosis in young children; highly effective therapies that aim to correct the defective protein responsible for the clinical manifestations of cystic fibrosis are becoming more widely available. This proposed investigation will characterize chronic rhinosinusitis and olfactory dysfunction in young children with cystic fibrosis and determine the degree to which highly effective therapies improve these complications. Findings from this investigation, which are aligned with cystic fibrosis community research priorities, will inform optimization of both quality of life and overall health, and will highlight the importance of evaluating and managing comorbidities at a young age.